Defining microbial metabolic interactions in polymicrobial environments

PROJECT SUMMARY
Polymicrobial communities are ubiquitous and the interactions between microbes are critical drivers of overall
community function. The commensal, pathogenic, and mutualistic organisms in host-associated microbial
communities display synergies as a direct result of the interplay between their metabolic activities and spatial
arrangement relative to each other, leading to sustained cooperative and competitive interactions. However, the
fundamental biological principles of how microbes interact and the spatial constraints to these interactions, from
the macro to micron to chemical scale, remain largely unknown. To fill this knowledge gap, we propose
interdisciplinary approaches to map the nutritional landscape and determine how the nutritional landscape
impacts microbial community assembly, spatial organization, and interactions within host-associated microbial
communities. Here, we use chronic wounds as a model system, as they have features conducive to addressing
our goal: 1) sustained interactions in their native environment; 2) access to in situ sampling and visualization;
and 3) measurable outcomes of interactions. Our objective is to combine top-down and bottom-up approaches
to define the processes by which structured microbial communities form, the molecular mechanisms governing
interactions between microbes, and the spatial parameters that dictate microbe-microbe interactions. First, we
will use high-resolution confocal imaging, imaging mass spectrometry, and spatial metatranscriptomics to
quantify the metabolic landscape of polymicrobial communities, in three-dimensions at the micron scale with an
innovative computational pipeline we developed. This will yield an unprecedented view of microbes in their
natural environment and provide a platform for visualizing polymicrobial communities. Further, we will evaluate
how this landscape shifts in response to changes in community composition and host environment. Next, we will
use -omic and genetic approaches to define how shifts in nutrient availability due to changes in community
composition and host nutritional status impacts cellular metabolism, cooperation, and competition within
microbial communities. Collectively, this proposal will provide a framework for understanding the ecological
factors that contribute to community composition, stability, and interactions in host-associated polymicrobial
environments. While this project is centered on chronic wounds, the long-term goal is to apply this platform
broadly across microbial communities. This work will advance our fundamental knowledge of microbe-microbe
interactions and identify new strategies that leverage these interactions to improve human health.

Public health relevance
PROJECT NARRATIVE While interactions between microorganisms in microbial communities are critical for overall community function, the fundamental biological principles that govern how microbes interact in complex host-associated polymicrobial environments are poorly understood. To address this gap, this proposal aims to build a robust platform to define the molecular mechanisms of microbe-microbe interactions and generate a molecular blueprint of these interactions in host-associated communities. Ultimately, this research program will inform our understanding of the molecular and ecological mechanisms that drive microbial interactions in host-associated polymicrobial environments and identify novel strategies to leverage these interactions to modulate community function.